Core C: Data Management and Statistical Core

The primary mission of the Data Management and Statistics Core (DMSC) is to provide leadership and
expertise in all phases of data collection, management, and analysis, from development of new research
projects to publication of results. Our overall aims are to maximize the impact of the Boston University
Alzheimer's Disease Research Center (BU ADRC) resources by ensuring sound experimental and analytical
design, to harmonize, integrate, and share research data generated by the BU ADRC, and provide the
analytical tools and expertise investigators need to advance the field of AD and ADRD research.
The main objectives of the DMSC are to 1) maintain an integrated, user-friendly data management system that
provides the highest quality data, security, and integrity; 2) to provide active and integral collaboration in
methodological design and statistical analysis to all ADRC Cores and investigators; and 3) to provide systems
and support for user-driven analysis and resource sharing, including uniform data for the National Alzheimer's
Coordinating Center (NACC), as well as managing systems for provision of data, tissue, and participant
information for ADRC and other collaborators. The DMSC has considerable experience in systems and
procedures, including: (i) centralization and integration of all ADRC data systems, and system enhancements
to ensure data confidentiality and security, (ii) integration of new data collection instruments and electronic data
capture modules, (iii) integration of CTE projects and the RHI cohort in ADRC data base infrastructure, (iv)
development of new statistical methodologies. The DMSC will expand and enhance ADRC systems including
state-of-the-art hardware, software and expertise, to effectively manage and analyze research data generated
by the ADRC. Careful coordination and cooperation with all data-generating cores is a critical component of
our plan to integrate and maximize the effectiveness of our diverse daa. We will leverage BU resources,
including expertise in cutting-edge statistics, bioinformatics, and machine learning to implement best-practice
management and analysis of data resulting from the ADRC.
1. To provide and maintain centralized data management, harmonization, and integration of the rich and
diverse data sources generated by all other ADRC cores. 2. To maintain, enhance, and extend software tools
and infrastructure that enables qualified investigators to access and interact with all managed data. 3. To
provide advice, expertise, and training in the design and conduct of data analysis projects using DMSC
managed data. 4. To develop novel analytical methods in support of ADRC research aims.